Deciphering the role of heterochromatin in telomere function and maintenance mechanisms

PROJECT SUMMARY
Telomeres are nucleoprotein structures that protect the ends of linear chromosomes and thereby
maintain genome stability. Telomeres solve both the end-protection and the end-replication problems: 1)
They inhibit DNA damage at chromosome ends, which would otherwise resemble broken DNA, 2) Since
chromosome ends shorten during replication, telomeres act as buffer sequences to prevent loss of coding
regions, 3) Once telomeres become too short, they can no longer inhibit DNA damage, leading to
permanent cell cycle arrest (senescence). This “mitotic clock” is a critical tumor-suppressive barrier that
forces aging cells to stop dividing. To become cancerous, cells must acquire unlimited division potential
by activating a telomere maintenance mechanism, either reactivation of telomerase, the enzyme that
elongates telomeres during development, or through the alternative lengthening of telomeres (ALT)
mechanism, which is based on recombination.
ALT+ cancers cells are characterized by clustering of telomeres into ALT-associated PML bodies (APBs)
that serve as platforms for telomere recombination. ALT+ telomeres also display singular chromatin, with
a lower nucleosome density and loss of the ATRX/DAXX pathway that normally deposits H3.3 at
telomeres. We found, however, that H3K9 trimethylation at telomeres promotes formation of APBs, as
well as subsequent ALT activity. We propose here to determine which chromatin regulators as well
as DNA damage and repair genes modulate APB formation in ALT+ cells.

Public health relevance
PROJECT NARRATIVE Telomeres are nucleoprotein structures that protect the ends of chromosomes from replicative erosion, nucleolytic degradation and from the DNA damage signaling and repair pathways. To acquire unlimited potential of division, cancer cells need to activate a mechanism of telomere elongation. In ALT+ cancers, telomere elongation depends on recombination events that occur within ALT-associated PML bodies, which we propose here to characterize.